North Carolina Translational and Clinical Science Institute (NC TraCS)

Contact PD/PI: Buse, John B
Overall Abstract
Since our inception in 2008, the UNC CTSA affiliate, the North Carolina Translational and
Clinical Sciences Institute (TraCS) has transformed clinical and translational science at UNC
through interdisciplinary research, training, collaboration with partners and stakeholders, and
strong engagement across the CTSA consortium. We have built a dynamic regional network of
universities, research institutes, health care providers, and >130 community organizations
across our state. In the coming funding period, we propose to add NC State University in
addition to RTI International and NC A&T University as full partners in our CTSA hub. Our
research infrastructure has engaged 3,234 registered members, resolved 11,147 research
service requests, trained 63 faculty in our KL2 program, and supported 705 pilot grants,
resulting in >$170M in external research funding, and >600 published manuscripts that have
been cited >21,000 times. TraCS developed Join the Conquest, an online engagement tool to
increase participation in clinical trials, that includes over 6,000 registered participants and over
200 unique research studies. The TraCS 4D Strategic Initiative and KickStart Program have
facilitated 141 invention disclosures, 99 patents, 40 licenses, $57M in SBIR/STTR grants, and
the creation of 68 new companies.
Over the next five years, we will translate the best science from UNC and across the CTSA
consortium into creative, effective, and accessible clinical and community interventions,
addressing the public health problems of our state and advancing national CTSA goals by
completing our Overall Aims. Aim 1 Workforce Development: Develop and support a skilled
and diverse clinical and translational research workforce to advance translational innovations
and address healthcare priorities. Aim 2 Collaboration and Engagement: Engage diverse
stakeholders as active partners in translational research, and promote innovative approaches to
team science. Aim 3 Integration: Integrate translational research across the research
continuum, disciplines, populations, and throughout the lifespan; Aim 4 Methods/Processes:
Develop and disseminate innovative methods and approaches to address scientific and
operational barriers to translating scientific findings. Aim 5 Informatics: Incorporate cutting-edge
informatics tools and methodologies in every aspect of translational research.
We believe that we have made exceptional strides in engaging our partners and our community
in our activities and are well positioned to advance our mission as a public university CTSA.
Going forward, we will further engage our stakeholders in the research process; train the next
generation of translational researchers to flourish within interdisciplinary teams; effectively
synergize clinical research with health care to identify unmet needs and implement solutions,
particularly for populations at risk for poor health outcomes; and rapidly disseminate our findings
to our patients, our community partners, and the CTSA Consortium.
Project Summary/Abstract Page 176
Contact PD/PI: Buse, John B

Public health relevance
PROJECT NARRATIVE The North Carolina Translational and Clinical Sciences Institute (TraCS) is the integrated hub of the NIH Clinical and Translational Science Awards (CTSA) program at the University of North Carolina at Chapel Hill (UNC). Over the next five years, we will apply our expertise and infrastructure to support clinical and translational research, to advance health care for North Carolinians and the national goals of NCATS. Project Narrative Page 177